Structural mechanisms of FoxM1 regulation

Project Summary
The goal of this research project is to characterize the molecular mechanisms regulating FoxM1 in
cell proliferation. The FoxM1 transcription factor increases gene expression to drive the cell cycle and
division. FoxM1 expression and activity are high and necessary in many human cancer cells, and thus
FoxM1 is an attractive therapeutic target. We propose and will test a novel structural model for FoxM1
regulation, in which activity is modulated by conformational switching of an intrinsically disordered
transactivation domain (TAD). We will determine the structure of inactive FoxM1, in which the TAD is
bound and sequestered by a negative regulatory domain (NRD). We will also test hypotheses for how
Cyclin-dependent and Polo-like kinases phosphorylate FoxM1, releasing the TAD from the NRD and
enhancing a helical structure that binds the transcription coactivator protein CBP. These studies will
provide fundamental new insights into cell cycle control through multisite phosphorylation and inform
future strategies for developing therapeutics that inhibit FoxM1 and its role in cell division.

Public health relevance
Many diseases have defects in the biochemical mechanisms that regulate cell growth and division, so understanding how these processes work is vital to understanding human health and developing therapeutics. This project aims to develop a molecular picture of how the protein FoxM1, which stimulates cell proliferation, is regulated.